Analytical and Clinical Validation of an EPIC 900K v2 array-based methylation assay to predict recurrence in stage II melanoma

PROJECT SUMMARY
In contrast to breast and colon cancers, where molecular pathology tests are routinely used to improve the
accuracy of disease prognostication over routine histopathology, there are no validated molecular tests for locally
advanced, node-negative melanoma (Stage II). Existing molecular biomarkers, particularly commercial tests
developed to manage localized melanoma, have not robustly demonstrated clinical validity or utility as evidenced
by the lack of recommendation by the National Comprehensive Cancer Network Melanoma Guidelines and other
organizations. Recently, pembrolizumab, an anti-PD-1 immunotherapeutic agent, was approved as adjuvant
therapy for surgically resected stages IIB and IIC melanoma based on data from a randomized, placebo-
controlled clinical trial. Although recurrence-free survival (RFS) at the 18-month post-surgical follow up showed
a statistically significant benefit associated with pembrolizumab, the RFS in the placebo group is fairly high.
Given the potential toxicity of immunotherapy, and its variable efficacy and high cost, we need more accurate
tools to appropriately select patients who have a high probability of tumor recurrence, and spare surgically cured
patients the risks of overtreatment. Several publications, as well as our own preliminary data have identified
strong associations between aberrantly methylated DNA loci and melanoma survival outcomes. Indeed, we
identified a 13-probe signature using the EPICMethylation v1.0 array that was highly accurate in identifying
melanoma recurrence and mortality among patients with stage II melanoma. The goal of the current proposal is
to refine and validate (analytically and clinically) the recurrence prediction signature using a large prospective
cohort of stage II melanoma patients whose tumors are analyzed with the updated MethylationEPIC v2.0 array.
The UH2 phase will establish the minimum amount of tumor needed to reliably detect a melanoma signature
(technical sensitivity), and will establish the precision and reproducibility of the assay. We will also examine the
potential interfering effect of melanocytic nevi when they are associated with melanomas, and will conduct inter-
laboratory harmonization studies prior to the UH3 studies. In the UH3 phase, we will use the analytically validated
assay to: 1) analyze stage II melanoma tumors from a prospective cohort of patients with a minimum of three
years of follow up data (among non-relapsed patients); 2) refine the recurrence prediction model; and 3) validate
the model in a separate group of patients. The final deliverable will be a recurrence-prediction model that
combines clinicopathological factors with a set of differentially methylated loci to more accurately classify patients
into high- or low-risk for recurrence than a model based on clinicopathological factors alone. Since the Infinium
MethylationEPIC BeadChip v2.0 array is currently in use in clinical laboratories, the results of this project could
be quickly tested in other patient cohorts, incorporated into clinical utility trials, and broadly disseminated to the
health care community at large.

Public health relevance
PROJECT NARRATIVE Stage II melanoma patients have a pressing medical need for more accurate tools to inform them of their risks for recurrence, which will help them decide whether to undertake expensive and potentially toxic adjuvant immunotherapy. The immediate goal of this project is to refine and validate (analytically and clinically) a recurrence prediction signature using the Infinium EPICMethylation v2.0 array. The overall goal of this research is to deliver a novel methylation-based recurrence-prediction model that can be: 1) broadly adopted by multiple clinical laboratories; and 2) tested in prospective clinical trials to identify high-risk stage II melanoma patients for adjuvant therapy, and spare low-risk patients (e.g. surgically cured patients) unnecessary treatment.